ELUCIDATING THE ROLE OF COATOMER COMPLEX COPI IN SKELETAL DYSPLASIA

PROJECT SUMMARY
This proposal describes a five-year mentored training experience designed to prepare the applicant for a career
in basic and translational science research. The applicant holds M.D. and Ph.D. degrees, and is certified by the
American Board of Medical Genetics and Genomics. The applicant’s long-term goal is to become a physician-
scientist studying the molecular genetic basis of skeletal dysplasias. The career development plan includes
mentorship, formal coursework, lab meetings, seminars, national conferences, and meetings with the advisory
committee. The plan is designed to broaden the applicant’s research skills, including coursework and
experimental learning in model organisms, glycoproteomics, microscopy imaging, and biostatistics. In addition,
the proposed plan will provide training in leadership, mentorship, laboratory management, scientific writing and
editing, grant writing, and the ethical implications of research. The Department of Molecular and Human Genetics
at Baylor College of Medicine has a long track record of training highly successful physician scientists. The
mentor, Dr. Brendan Lee, is a leading expert in the field of skeletal dysplasia and has been the primary research
mentor for over 9 K and VA career development awardees, all of whom have gone onto independent laboratory-
research based careers. The advisory committee was selected to complement the mentor’s expertise and to
provide important research and career guidance for the applicant. The proposed study will investigate the
functional, cellular, and biochemical consequences of COPB2 haploinsufficiency in bone. Loss-of-function
variants in COPB2, a subunit of the COPI coatomer complex, were identified in children with developmental
delay and bone fragility. The COPI functions in trafficking between the ER and Golgi, and within the Golgi
cisternae. Vesicular trafficking defects, including COPI dysfunction, have been implicated in skeletal dysplasia.
Preliminary data demonstrated that Copb2+/- mice exhibit a low bone mass phenotype, and copb2-null zebrafish
embryos show abnormal secretion of procollagen. The applicant proposes that COPB2 deficiency leads to bone
fragility by causing delayed collagen trafficking, Golgi-ER dysfunction, and altered autophagy, resulting in
disruption of osteoblast differentiation. The proposed study involves analysis of the skeletal phenotype in
COPB2-deficient mouse models, including selective deletion of Copb2 in bone during specific stages of
osteoblast cell differentiation (“conditional knock-out”). By taking this approach, the applicant will determine at
which time point during skeletal development the deficiency of COPB2 becomes critical. The proposed study
also aims to check if COPB2 deficiency alters protein glycosylation, and causes an ER-Golgi dysfunction, and
whether these changes may be amenable to therapy. The study will involve the analysis of COPB2-deficient
mouse models and cells. This application, which provides a broad research experience and utilizes advanced
technologies, and the proposed career development plan will prepare this applicant for a career as an
independent research scientist.

Public health relevance
PROJECT NARRATIVE The proposed project will investigate why children with COPB2-related disorder have osteoporosis and bone fractures. Results from this study will assist in developing better diagnostic approaches and therapies for these patients and will provide insights relevant to other genetic disorders that affect protein secretion.